mRNA encoding of immune receptor-targeting antibodies for the augmentation of vaccine-elicited cellular immunity.

Project summary.
Clinically relevant cellular responses to either experimental or FDA approved vaccine adjuvant formulations
have been difficult to generate and/or detect. We have long been investigating a combined adjuvant
formulation (composed of a TLR agonist and an agonistic antiCD40 antibody) which generates cellular
immunity on par with that observed to infectious challenge. The complexity of this three-part vaccine (antigen
plus TLR/CD40) is limiting to its clinical application. However, the success of lipid nanoparticle (LNP)
encapsulated mRNA vaccines for Covid provides a possible avenue by which our combination adjuvant might
be successfully translated into clinical use against chronic infectious diseases and cancer. Our preliminary
results show that we can agonize the CD40 pathway, sufficient to augment CD8 T cell responses, by mRNA-
mediated delivery of the heavy and light chains of the agonistic anti-CD40 antibody FGK45. The success of
this method for targeting CD40 strongly favors the hypothesis that antibodies specific for other
immunotherapeutic molecular targets (eg. CTLA4, PD1) might also be successfully delivered via the mRNA
vaccination strategy. Completion of this project would not only identify a new and powerful means by which
the established potency of our combined adjuvant might be leveraged for clinical application, they open an
entirely new paradigm in the use of mRNA vaccination for targeting immunologically relevant molecules for the
purposes oncologic checkpoint therapy and beyond.

Public health relevance
Project Narrative Most vaccines that protect us from infections make really strong antibody responses. However, there are other cells in the immune system, like T cells, that are not very well activated by these vaccines. The most recent mRNA vaccines that have been so successful against Covid19 are good examples of this. While this is fine if we are trying to protect ourselves from getting an infection, this does not work very well if you have a chronic infection or cancer. Immune-mediated therapeutic intervention in those cases requires the participation of T cells, and a lot of them. The success of the new mRNA vaccines however provide an opportunity for us to solve this problem. We know there are certain triggers in the immune system that help specifically boost T cells responses. One of them, a molecule called CD40, works particularly well in the context of vaccination to dramatically increase the number of T cells responding to the vaccine. In this project, we tried to deliver a strong stimulus through this CD40 immune trigger via mRNA vaccination, and it worked. Our research project will first explore how to optimize delivery of this stimulus through different forms of the mRNA vaccine. The success of our first experiments indicate that we might also be able to use the same method to target other molecules that are really important in immune responses. The second goal of this project is to measure how good our mRNA vaccine delivery method might be when we try and target two other molecules (CTLA4 and PD1) that have already been shown to be important in making strong T cell responses against cancer.